Iowa Cochlear Implant Clinical Research Center Project VIII

Program Director/Principal Investigator (Last, First, Middle): Gantz, Bruce J.
PROJECT SUMMARY – CORE A
The purpose of the Administrative Core is to maintain the cohesive and efficient operation of the Iowa
Cochlear Implant Clinical Research Center Grant (ICICRC). It provides the personnel and facilities for a central
administrative structure that ensures the successful management of this multidisciplinary project. The
Administrative Core will also monitor the scholastic and scientific merit of the research program.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Gantz, Bruce J. NARRATIVE See Overview for project narrative for the project’s relevance to public health.